Dietary Regulation of Intestinal Inflammation and Repair

PROJECT SUMMARY
Inflammatory bowel diseases (IBD), which include both ulcerative colitis and Crohn's disease, are estimated to
affect three million individuals in the United States, and the number of people living with IBD continues to rise.
Currently available medications are costly, ineffective for some patients, and associated with serious risks
including opportunistic infections, hepatic inflammation, pancreatitis, and cancer. Thus, there is an urgent need
to improve our understanding of the modulators of intestinal inflammation and repair in order to identify novel
therapeutic targets to treat and prevent IBD. The microbiota is the source of various metabolites which can exert
their effects at the site of absorption (intestine), and at distant sites such as brain via bloodstream. In this regard,
the microbiota mimics an endocrine organ, and its output has only begun to be understood. Since various dietary
components, such as dietary fiber, influence the levels of microbiota-derived metabolites, many of the effects of
diets on immune cells could be mediated via the microbiota. Although dietary fiber has some anti-inflammatory
effects, IBD patients are often instructed to limit their fiber consumption to reduce the frequency and severity of
disease flares. However, the mechanism behind dietary fiber-induced exacerbation of IBD-associated symptoms
is poorly understood. In new preliminary studies, we identified that a fiber-rich diet activates ILC2s in the colon
and significantly increases the levels of eosinophils, a type 2 inflammatory immune cell regulated by ILC2s. The
effects of dietary fiber on the eosinophil responses are dependent on the microbiota and are associated with
remarkable changes in microbiota-derived metabolites. Furthermore, the high fiber diet increased disease
severity in a murine model of intestinal damage and inflammation. Despite these observations, the mechanisms
through which dietary fiber regulates the ILC2-eosinophil axis and colonic inflammation remain unknown. Based
on our new preliminary data, we hypothesize that microbial metabolites regulate colonic ILC2s and that
alterations of these metabolites by a high fiber diet induce pathologic activation of ILC2s and severe intestinal
inflammation. We propose to generate a detailed understanding of how microbial metabolites influence
inflammatory pathologies in murine models of intestinal inflammation and examine these pathways in human
IBD patient samples. In Aim 1, we will determine what microbial metabolites and host metabolite receptors are
involved in the high fiber diet-induced type 2 inflammation and their role in intestinal damage and inflammation.
In Aim 2, we will employ a novel CRISPR-based microbial gene-editing technique to directly test the microbial
metabolic pathways through which a high fiber diet mediates intestinal inflammation. In Aim 3, we will translate
these findings to human disease and determine how alterations in microbial metabolites and the ILC2-eosinphil
axis correlate with clinical and endoscopic measures of IBD disease activity. In addition to uncovering novel
immunoregulatory mechanisms of diet and microbiota and their unique roles in IBD, these studies will provide
preclinical justification for development of novel therapeutics to target this pathway.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel disease is a chronic illness that represents a significant public health and economic burden, and there is an urgent need to improve our understanding of modulators of intestinal inflammation in order to identify novel therapeutic targets. Based on our recent findings that specific diet-induced microbial metabolites trigger pathologic activation of the group 2 innate lymphoid cells (ILC2s) and associated type 2 inflammation, the focus of this proposal is to dissect the role of this diet-microbiota axis in the regulation of intestinal inflammation.